Administrative Core

Administrative Summary
The Administrative component of the Pediatric Center of Excellence in Nephrology (PCEN) is charged
with oversight and organization of all of the activities of Center. The Program Director, R. Ariel Gomez will
be responsible for the scientific coordination, the direction of research emphasis and the overall
administration of the Center. Drs. Patricio Ray and Maria Luisa Sequeira-Lopez, senior principal
investigators (PIs) of two of the Center projects will assist him in scientific and administrative matters
including the Pilot and Feasibility (P&F) program (Dr. Ray) and the Enrichment program (Dr. Sequeira-
Lopez). Furthermore, Dr. Ray as the Minority Recruitment Officer will implement in collaboration with the
Office for Diversity, Equity and Inclusion a recruitment plan to attract scientists from underrepresented
minorities groups. The Executive committee, composed of Dr. Gomez and all the project PIs with the
internal and external advisory committees will oversee the P&F program, the Enrichment program and the
functioning of the Core. The internal and external advisory committee members are experts in the central
scientific theme of the Center. Those advisors will visit and evaluate the whole program each year and
make recommendations regarding the suitability, funding and continuation of P&F projects and the
direction of the center. The Administrative component will continue to maintain a fully developed website
that describes the Center,highlights the research accomplishments of individual projects and the Core in
Single Cell Epigenomics, Transcriptomics and Bioinformatics, advertises the call for applications to P&F
awards (in coordination with the 2 other PCENs), and publicizes the seminars and symposia provided
through the Enrichment program. Furthermore, all the opportunities and activities will be advertised in the
PCEN Twitter and Facebook accounts. The University of Virginia provides extensive research facilities
with numerous additional core labs to guarantee an exceptional environment for the research activitiesof the
Center investigators. In further support of the Center, the institution has committed funds for salary,
reagents and educational enrichment activities. The PCEN will continue to collaborate with the adult
Nephrology Division via a Pediatric and Adult Nephrology U2C/TL1 training grant, with the Integrated
Translational Health Research Institute of Virginia (iTHRIV), the Center for Public Health Genomics, the
new School of Data Science, the Cardiovascular Research Center (T32) and all the O’Brien and PCENs
through the NOCKS series as well as establishing common PCEN workshops and annual symposia.